Novel integrative method to detect biomakers of breast cancer resistance

DESCRIPTION (provided by applicant): Triple-negative breast cancer (TNBC) is defined by lack of expression of estrogen receptor (ER), progesterone receptor (PR), and human epidermal growth factor receptor 2 (HER-2) and is characteristically an aggressive cancer, especially in a metastatic setting. Approximately 15-20% of all breast cancers are TNBC. In spite of recent improvements in TNBC treatment, the lack of known specific therapeutic targets and the heterogeneous response to chemotherapy make it difficult to attack TNBC and obtain a consistent outcome and meaningful benefit. Recently, cisplatin chemotherapy has regained interest based on growing evidence on achieving better outcome from preclinical and clinical data. However, many TNBC patients are not responding to the treatment; and there is no clinical practical way to identify in which individuals' cisplatin chemotherapy will be effective t avoid unnecessary toxicity and cost of healthcare. The objective of this study is to develop a computational framework, based on signal processing and machine learning techniques, for identifying novel cisplatin response candidate biomarkers in TNBC more accurately and efficiently from next-generation sequencing (NGS) data. The recent discovery of the p63/p73 expression, p53 mutation and measurements of DNA repair status effects on the sensitivity to cisplatin in TNBC patients has indicated the existence of cisplatin response predictors and the need for further investigation. In this study, we will develo a novel sequence-based copy number variation (CNV) detection tool, using signal processing techniques; and a novel supervised integrative analysis tool, based on Bayesian network analysis which integrates CNV, point mutation and gene expression data. We will hone and validate the innovative methods and tools on publically available data such as The Cancer Genome Atlas (TCGA) data. Then by collaborating with oncologists and pathologists from Beth Israel Deaconess Medical Center (BIDMC) and using the Dana- Farber/Harvard Cancer Center DNA Resource Core services, we will generate novel DNA sequence and RNA- seq datasets on responsive and non-responsive TNBC tumor samples from an existing clinical trial, which was designed to study preoperative cisplatin in early-stage breast cancer. By applying the proposed computational framework we will shed unprecedented light on potential predictors of TNBC response to cisplatin therapy that can help guide biomarker selection. We will verify the candidate biomarkers through gene ontology and pathway analyses. In addition, we will analyze TCGA data to determine the prevalence of these candidate biomarkers in TNBC.

Public health relevance
PROJECT NARRATIVE The objective of this study is to develop a computational framework, based on signal processing and machine learning techniques, to more accurately and efficiently identify novel cisplatin response candidate biomarkers in triple negative breast cancer (TNBC) from next-generation sequencing data. Successful completion of this proposal will result in two important public health impacts: (1) Candidate "response" biomarkers of cisplatin chemotherapy responsive TNBCs, and (2) A computational approach supporting personalized medicine for TNBC. Furthermore, once established, this framework can be extended to the detection of biomarkers in other tumor types, and can contribute to improving the drug development process and the effectiveness of cancer care. __SpecificAimsTextDelimiter__ SPECIFIC AIMS High-throughput genomic profiling has tremendous potential as a technology to identify new and clinically valuable biomarkers for the diagnosis, prognosis and treatment of cancer. Triple-negative breast cancers (TNBC) are excellent subjects for whole molecular profiling because they lack targeted treatments, are heterogeneous, and vary in their response to chemotherapeutic agents. Approximately 15-20% of all breast cancers are TNBC, defined by a lack of expression of the estrogen receptor (ER), progesterone receptor (PR), and human epidermal growth factor receptor 2 (HER-2). Among a few treatment options for TNBC, cisplatin chemotherapy has regained interest based on growing evidence of better outcomes suggested by preclinical and clinical data. However, many TNBC patients are not responding to treatment, and there is currently no clinical, practical way to identify the individuals for whom cisplatin chemotherapy will be effective in order to avoid unnecessary toxicity and healthcare costs. The objective of this study is to develop a computational approach, based on signal processing and machine learning techniques to identify novel cisplatin response candidate biomarkers in TNBC more accurately and efficiently from next-generation sequencing (NGS) data. The recent discovery of the effects of p63/p73 expression, p53 mutation, and measurements of DNA repair status on TNBC patients' sensitivity to cisplatin indicates the existence of cisplatin response predictors and the need for further comprehensive investigation. We will develop a novel, more efficient, and accurate copy number variation detection tool and a novel, more precise supervised integrative analysis tool, which wil integrate CNV, point mutation, and gene expression data to help guide biomarker selection. We will refine and validate the algorithms using publicaly available data, such as The Cancer Genome Atlas (TCGA) data and simulated data. Then, by collaborating with oncologists and pathologists from Beth Israel Deaconess Medical Center (BIDMC), we will generate DNA sequence and RNA-seq datasets from responsive and non-responsive TNBC tumor samples from an existing clinical trial. The application of these proposed methods will shed unprecedented light on potential predictors of TNBC response to cisplatin therapy that can help guide biomarker selection. Successful completion of this proposal will result in two important public health impacts: (1) Candidate "response" biomarkers of cisplatin chemotherapy responsive TNBCs, and (2) A computational aproach supporting personalized medicine for TNBC. Furthermore, once established, this approach can be extended to the detection of biomarkers in other tumor types, and can contribute to improving the process of drug development and the effectiveness of cancer care. To achieve the overarching objective of this study, we will pursue the following specific aims: Aim 1: Develop a novel copy number detection method based on signal processing techniques. CNVs are associated with cancers through the amplification of oncogenes and the deletion of tumor suppressor genes. Comparative analysis of sequence-based CNV detection tools has shown that consensus CNVs are few and their false positive rates are high. To address the limitations of current CNV detection methods, we will develop an efficient, sequence-based CNV detection method based on a signal processing approach, which uses wavelet transforms for noise cancellation and compress sensing techniques for CNV detection. We will test and validate this method using publically available and simulated data. Aim 2: Develop a novel supervised integrative analysis method to identify response predictive genes. Analyzing gene expression has been long used to identify genes that are associated with phenotypes. However, because of the dependency among the over-expressed and/or under-expressed genes, analyzing gene-expression data is not sufficient to accurately identify causal or driver genes. In order to identify treatment response predictive genes more precisely, we will develop an innovative, supervised integrative analysis (SIA) method based on module network and Bayesian analysis, which integrates sequence-based gene expression, point mutation, and CNV data. The output of this algorithm will be a list of treatment response driver genes as candidate predictive biomarkers. We will test and validate this method using publically available and simulated data. Aim 3: Apply the SIA method to identify candidate cisplatin response predictive biomarkers. By collaborating with BIDMC oncologists and pathologists and using the Dana-Farber/Harvard Cancer Center DNA Resource Core services, we wil generate high-quality DNA sequence and RNA-seq datasets on 5 cisplatin responsive and 5 non-responsive prospective TNBC tumor samples from an aproved and forthcoming clinical trial investigating cisplatin usage in breast cancer treatment. Using these datasets, we will apply the methods and pipelines developed in Aim 1 and Aim 2 to identify the candidate cisplatin response predictive genes as potential biomarkers. To verify these candidate biomarkers, we will apply gene ontology annotation and pathway analysis, and will select genes that are functionally important for TNBC. For further validation, we will analyze TNBC TCGA data to obtain the prevalence of these candidate biomarkers.